Administrative Core

PROJECT SUMMARY
The Administrative Core (AC) for the Midwest Murine-Tissue Mapping Center (MM-TMC) for Senescent Cells
(SnCs) will be led by three PIs with synergistic expertise and extensive experience leading multidisciplinary
research centers: Dr. David Bernlohr (UMN), an expert in adipose biology, lipid signaling, and more recently
cellular senescence; Dr. Sundeep Khosla (Mayo), an expert in bone biology, cellular senescence, and mouse
models to clear and report SnCs; and Dr. Scott Budinger (Northwestern), an expert in lung biology, single cell
transcriptional profiling, and the biology of aging. The main goals of the AC are to facilitate interactions between
the MM-TMC cores to maximize the TMC’s productivity, to create a seamless interface between the MM-TMC
Data Analysis Core (DAC) and the SenNet Consortium Organization and Data Coordinating Center (CODCC),
and to promote interactions with other human and mouse TMCs and UG3s (Technology Development Projects).
The specific responsibilities of the AC are to i) coordinate and oversee the MM-TMC cores to facilitate access
to murine tissues, data collection, analysis, and integration; ii) administer a pilot project program focused on
developing innovative approaches to identify and characterize SnCs; iii) coordinate MM-TMC activities with those
of other TMCs to enhance the rigor and reproducibility of mapping SnCs in mice and using mouse data to inform
the human SnC mapping efforts.; iv) facilitate communication between the our DAC and the CODCC to ensure
adherence to standard operating procedures (SOPs) and definitions of common data elements and to enable
timely data submission; v) facilitate collaborations between the MM-TMC team and SenNet that will yield
network-wide metrics for data generation and metadata standards, inter-TMC and TMC-UG3 collaborations and
cross-training, and a cohesive plan for the development of data analysis and visualization tools for the broader
scientific community. The Specific Aims of the MM-TMC AC are to: 1) Oversee and coordinate efforts of the
MM-TMC to ensure that research goals and milestones are met with highest quality standards; 2) Integrate input
from the MM-TMC DAC and the SenNet CODCC to develop and ensure compliance with SOPs for generating
data sets that enable the development of a multi-dimensional atlas of SnCs with healthy mouse aging. 3) Oversee
and coordinate the exploration and evaluation of novel approaches for detecting, deeply phenotyping, tracing,
and perturbing SnCs as technologies emerge from pilot projects, UG3 projects, other TMCs, and external groups
studying SnCs or building cell atlases; and 4) Coordinate the activities of MM-TMC with other TMCs to optimize
research efficiency and economies of scale and scope, including contributing to the adoption and/or further
development of data standards, analytic tools, data sharing/visualization/discovery tools, and multi-site studies
and training. Successful execution of these aims will optimize the operations of MM-TMC, maximize our
contribution to SenNet, and ensure compliance with SenNet SOPs that support rigor and reproducibility.